SToP Cancer SPORE: Administrative Core A

CORE A: ABSTRACT
The Administrative Core (Core A) supports the work of this SToP Cancer SPORE. The Administrative Core and
its leadership team led by Dr. Yeh will be responsible for strategic planning, management and commitment of all
project and core resources, and ensuring compliance with all university, federal, and specific NCI/NIH grant
regulations and requirements, including timely communications and consultations with the National Cancer
Institute. Core A will oversee and facilitate all interactions with SPORE investigators and collaborators external
to UNC Lineberger. Additionally, Core A will coordinate all necessary meetings to administer the programmatic
operation of the SPORE, including meetings of the Executive Steering Committee, Internal Advisory Board,
External Advisory Board, and SToP Cancer SPORE investigators. Through this series of meetings, the Core
assumes responsibility for scientific oversight of the SPORE and will also oversee the activities of the
Developmental Research and Career Enhancement Programs. These functions will assist the SPORE
leadership in ongoing planning and evaluation of the program to ensure progress towards the accomplishment
of the proposed aims and resolve scientific disputes that arise. Core A will coordinate all human subject research-
related activities for compliance with institutional and federal regulatory requirements. In addition, Core A will
have overall fiscal responsibility for the SPORE to ensure cost-effective and efficient use of resources, including
the substantial institutional commitment to projects, infrastructure and recruitment allocated to leadership,
which approaches $7.5M over the 5 years of the SPORE.
Through these activities, the UNC SToP Cancer SPORE Administrative Core supports an exceptional team of
pancreatic cancer translational researchers as they seek to understand this deadly disease and its treatment,
advance new technology, and develop junior faculty into translational research leaders.

Public health relevance
CORE A: PROJECT NARRATIVE The Administration Core (Core A) is essential for leading the Selective Targeting of Pancreatic (SToP) Cancer SPORE. Core A will provide scientific, financial and administrative oversight for all SPORE activities and make critical decisions regarding oversight and management of projects and cores.